HUMAN AMYLIN ANALOGUE AC137 VS PLACEBO ON HEPATIC GLUCOGEN METABOLISM

This study is designed to see what the effects are of amylin analogue pramlitidine (AC137) on glucose (blood sugar) metabolism in insulin dependent diabetes mellitus. Amylin is a hormone normally produced by the pancreas. It is believed that people with Type I diabetes mellitus have very low levels of amylin in their blood stream. Evidence suggests that amylin may reduce post meal surges of blood glucose levels in people with Type I diabetes mellitus.